Effects of TNFalpha on Excitatory Synaptic Transmission

DESCRIPTION (provided by applicant): The regulation of the AMPA subtype of the glutamate receptor is believed to contribute to long term changes in synaptic strength; changes believed to be important for many forms of experience-dependent plasticity. The surface expression of AMPA receptors (AMPARs) appears to be tightly regulated despite their constant cycling. In addition AMPAR surface expression has been shown to rapidly increase or decrease in response to stimulation. The detailed molecular mechanisms underlying AMPAR receptor trafficking, however, remain elusive. In this proposal, I outline a series of experiments that will investigate how the inflammatory cytokine tumor necrosis factor-alpha (TNFalpha), which has been shown to alter excitatory synaptic transmission, impacts AMPAR trafficking. Preliminary data suggests that TNFalpha induces a robust and rapid increase in the surface expression of AMPARs in cultured neurons. I will confirm this observation and examine if this increase is occurring at synaptic sites. I will then test whether TNFalpha has an endogenous role in maintaining AMPAR surface expression and begin to determine the molecular signaling pathways involved. These data should significantly enhance our knowledge of AMPAR trafficking and the influence of TNFalpha on synaptic function.